Global significance test based on quantile regression with applications to genomic studies of Alzheimer’s disease

Project Summary/Abstract
Alzheimer's disease (AD) is one of the leading causes of death for the elderly with no current cure. Genomics
studies, such as mapping expression quantitative trait loci (eQTL) and differential gene expressions, play a
critical role in understanding the biological mechanisms of AD and developing potential therapeutic treatments.
In genomics studies, there has been growing awareness that the covariates (e.g., quantitative gene expression)
may have changing effects on the distribution of responses (e.g., disease phenotypes) reﬂecting a heterogeneous
covariates-response association. Those heterogeneous associations shed insight on scientiﬁc discoveries and
entail signiﬁcant implications but are often neglected by most existing analysis procedures conﬁned to a narrow
aspect of the response distribution (e.g., standard linear regression focusing on the mean or quantile regression
at a single quantile level). Thus, the development of valid and efﬁcient hypothesis tests to detect heterogeneous
associations is of great value to genomics studies of complex diseases such as AD.
This proposal aims to develop several quantile regression-based global signiﬁcance tests, which utilize all
information across a well-chosen region of quantile levels and provide researchers with evaluations of the overall
impacts of covariates on the response. Inspired by our preliminary data analysis on the two studies of aging and
dementia, namely Religious Orders Study (ROS) and Memory and Aging Project (MAP), we will ﬁrst propose
a global signiﬁcance test to thoroughly evaluate covariates' impact across all quantile levels of the response
variable (Aim 1). Then motivated by high-dimensional genomics data of AD in ROS/MAP, we will further develop
two global signiﬁcance tests for high-dimensional responses and covariates data, respectively (Aim 2). Moreover,
we will apply the proposed tests in Aims 1-2 to the genomics data generated by ROS/MAP to identify eQTL and
differentially expressed genes that can be used to prioritize risk genes of AD for identifying developing potential
treatments (Aim 3). We will also provide a user-friendly R package to implement the proposed tests.
The innovation of our proposal is three-fold. (i) By evaluating the impacts of covariates on responses across
the entire quantile domain, the proposed global signiﬁcance tests have a superior power to identify heterogeneous
covariates-response associations compared to alternative methods. (ii) As the proposed tests neither impose any
stringent model assumption nor require additional splines smoothing or re-sampling or shrinkage estimation, they
can be broadly implemented in large-scale genomics data. (iii) Our proposed test in Aim 2 will serve as a useful
tool for detecting heterogeneous associations between covariates and multiple responses.
The successful completion of this project will facilitate detecting heterogeneous associations and the
subsequent scientiﬁc discoveries in AD genomics studies for developing treatments. Moreover, our tests can
be applied to a broad scope of biomedical ﬁelds, resulting in a fruitful avenue for promoting public health.

Public health relevance
Narrative The novel global signiﬁcance test methods developed out of this proposal will provide useful statistical tools for testing heterogeneous covariates-response associations in broad biomedical researches. Our methods for handling data with high-dimensional responses and covariates will make our global tests especially useful for genomic studies of complex diseases that deal with thousands of genes and millions of SNPs. The ﬁndings out of our application genomic studies about Alzheimer's disease will not only validate our test methods but also curate a list of risk genes that are potentially important for developing therapeutic treatment.